Protocol Review and Monitoring System

PROJECT SUMMARY/ABSTRACT
The Perlmutter Cancer Center (PCC) Protocol Review and Monitoring System (PRMS), internally known as
the Protocol Review and Monitoring Committee (PRMC), reviews all cancer-related clinical research at PCC
and NYU Langone Health (NYULH). The objectives of the PRMC are to determine whether a protocol is
scientifically and statistically sound and to prioritize clinical research studies that are of the highest scientific
merit, particularly those that translate PCC science and address major cancer burdens and/or disparities in our
catchment area. The PRMC also evaluates whether research protocols compete with ongoing studies at PCC
and evaluates the likelihood of success of the work proposed. Scientific review is conducted through a two-stage
process for most protocols, with PCC Disease Management Groups (DMGs) providing the initial evaluation of
the scientific merit. The PRMC evaluates protocols after DMG review with the exception of investigator-initiated
trials (IITs), which have an additional review by the PCC Protocol Development and Monitoring Unit (PDMU) as
a quality control measure designed to enhance the chances of success for the protocol’s approval. The PRMC
also monitors ongoing clinical research studies for progress, reviewing IITs semi-annually and all other protocols
annually. The PRMC has the sole authority to terminate protocols that are not demonstrating appropriate
progress. PRMC review activities are coordinated with the actions of the NYU Langone Health (NYULH) IRB.
These two entities have distinct functions: the PRMC focuses on the evaluation of scientific merit and progress
of protocols, whereas the IRB evaluates protocols to ensure subject safety and address any ethical concerns.
Both work together to promote efficient activation of clinical trials. The PRMC ensures that all cancer-related
clinical trials at NYULH are appropriately designed and meet NIH policy and guidelines on the inclusion of
women, minorities, and children in clinical research. Hence, the PRMC functions in an integrated fashion with
the DMGs, the IRB, and other NYULH review bodies to facilitate rapid, efficient, equitable and inclusive clinical
research at PCC.